Tracking the evolution of breast cancer through single cell analyses of premalignant breast tissues from women at high risk for cancer development

Prophylactic mastectomy is currently the only breast cancer prevention strategy for women with inherited BRCA1
or BRCA2 mutations. While often effective, this strategy significantly impacts quality of life and does not prevent
the development of cancers arising in other tissues (e.g., pancreatic and prostate cancers). Thus, better
interception strategies are urgently needed. The overall goal of the parent grant is to characterize the earliest
alterations in breast tissues in individuals at high risk of developing breast cancer and to lay the groundwork for
the discovery of new prevention measures. Our collaborative studies with Dr. Sam Aparicio using single-cell copy
number analyses have identified expanded population of ostensibly normal breast epithelial cells from BRCA1/2
mutation carriers that carry copy number alterations (CNAs). Interestingly, these CNAs are among those that are
most commonly associated with early (DCIS) and established (IBC) forms of breast cancer and are present prior
to BRCA1/2 loss of heterozygosity (LOH), suggesting that these changes may predispose mammary epithelial
cells to tumor-initiating genetic alterations. This supplement proposal aims to test the overarching hypothesis
that the genetic alterations that occur prior to LOH of BRCA1 or BRCA2 allow cells to survive eventual loss of
both copies of BRCA1 or BRCA2, thereby increasing their cellular fitness and predisposition to malignant cancer
following accumulation of additional genetic alterations caused by defects in homologous recombination. We
plan to address this hypothesis by 1) complementing our CNA analysis by determining the single nucleotide
variant and mutational landscape of precancerous breast tissues using the Tapestri Platform (MissionBio), a
state-of-the-art, targeted single cell DNA and protein sequencing technology and 2) utilizing 3D breast organoid
models to determine the functional role of CNAs/SNVs in survival after loss of BRCA1/2 and whether additional
alterations downstream result in sensitization to tumor development. A better understanding of how early
CNAs/SNVs influence tumorigenesis can lead to the identification of vulnerabilities of these cells in order to
eliminate them before cancer progresses, as well as to develop strategies to detect expansion of aberrant cells
as a means of monitoring pre-malignant cell expansion. Importantly, accomplishing the goals of this proposal will
enable Dr. Oliphant to further strengthen the computational skills needed to analyze single-cell multiomic DNA-
seq and protein expression datasets independently, as well as leverage 3D organoid models to identify and
develop actionable therapeutic strategies more effectively. It will also provide Dr. Oliphant with opportunities for
engagement in various career development experiences including participating at conferences and expanding
his professional network. Overall, the funding of the proposed project will ensure that Dr. Oliphant expands his
scientific and professional training, while establishing the foundation for a viable independent academic research
program.

Public health relevance
Project Narrative The only effective means of breast cancer prevention in women with inherited BRCA1 or BRCA2 mutations is prophylactic mastectomy, but issues related to quality of life and other consequences highlight the need for better prevention strategies. This research project aims to develop more effective, non-invasive, tumor prevention approaches for high-risk mutation carriers by using single-cell technologies to profile genetic alterations in individual cells from normal breast tissues of women with wild-type or mutant BRCA1/2. We have identified expanded populations of ostensibly normal cells carrying copy number alterations (CNAs) and pathogenic single nucleotide variants (SNVs) in breast tissues of high-risk mutation carriers and will further investigate whether these genetic alterations predispose cells to survive loss of heterozygosity of BRCA1/2 and/or to progress to malignant cancer.